NIEHS Data and Specimen Repository

The Contractor shall provide management and support, as detailed in SOW, for data and specimens collected in NIEHS in-house or contract-supported research. Materials include a variety of biological and environmental specimens, and records in a variety of formats. This task is separate from the NTP Archives and FTB task.